MOLECULAR GENETIC ANALYSIS OF OBESITY &NONINSULIN DEPENDENT DIABETES

The aim of this study is to understand the molecular physiology of obesity in humans using candidate genes based mainly on rodent genetic models of obesity. The goal is to identify genes in which mutation and/or allelic variation in humans conveys susceptibility to obesity. Identification of these genes and their mechanism of action in human subjects will permit the rational subdivision of obesity into biologically meaningful subgroups that will, in turn, allow focused efforts to elucidate pathophysiology. The Children's Hospital of Philadelphia is one of several institutions from which samples are being collected for this study. To date twenty-one children have been enrolled at Children's Hospital of Philadelphia. These subject samples have been sent to Columbia-Presbyterian to be added to the data pool. There have been no problems in the recruitment of subjects or the completion of the protocol. Subject enrollment will continue as described above.